NCI, DCCPS IT Services and Support

To provide Information Technology (IT) support services including strategic planning, project management, enterprise architecture planning, operation and maintenance of the IT systems and development, operation, and maintenance of informatics projects.